Transforming growth factor β family signaling pathways in ovarian and uterine biology

PROJECT SUMMARY
The transforming growth factor β (TGFβ) superfamily is the largest family of secreted proteins in mammals.
These dimeric ligands, which function in nearly every developmental, physiologic, and pathophysiologic
process, including infertility, signal through a heterodimeric complex of type 2 and type 1 serine-threonine
kinase receptors that phosphorylate downstream regulatory SMAD proteins and bind SMAD4 to regulate
transcription. With NICHD support that started with a physician scientists award (K11HD00960; 1991-93) and
this R01 grant (1994-present), we have been productive leaders in the identification and characterization of the
oocyte-secreted TGFβ family members, growth differentiation factor 9 (GDF9) and bone morphogenetic protein
15 (BMP15), and granulosa cell-secreted activins and inhibins. We have published extensively in this field
including >30 papers in Nature, Nature Genetics, Nature Medicine, PLoS Biology, PLoS Genetics, PNAS, and
Science. Whereas mammalian oocytes were initially hypothesized to be passengers rather than drivers in
ovarian folliculogenesis, we showed that GDF9 is essential for fertility, discovered the X-linked BMP15 gene,
and showed that GDF9:BMP heterodimers are the most active oocyte-secreted ligand in mice and women.
These insights have defined the oocyte-somatic cell dialogue in ovarian folliculogenesis. In parallel, we showed
that inhibin α-knockout mice are infertile, develop ovarian cancers and die due to an activin-induced cachexia
syndrome. BMPs, GDF9:BMP15, activins, and myostatin share common type 2 receptors [activin receptor type
2A (ACVR2A) or type 2B (ACVR2B) or BMPR2], type 1 receptors (ALK4 and ALK5), and receptor-regulated
SMADs (SMAD1,2,3,5). Using mouse genetics, we have shown that these proteins function in the pituitary,
ovaries, and uterus (e.g., granulosa-specific knockout of SMAD2 and SMAD3 leads to cumulus defects and
infertility due to defective GDF9:BMP15 signaling, whereas uterine-specific knockout of SMAD2 and SMAD3
leads to infertility secondary to endometrial hyperplasia). Although SMAD2 and SMAD3 play redundant roles in
GDF9:BMP15, activin, and TGFβ signaling, we know little about the transcriptional complexes or DNA
sequences that they bind. In addition, there are no small molecule inhibitors of ACVR2A/2B and BMPR2. Our
overall hypothesis is that oocyte GDF9:BMP15, granulosa cell activins, and uterine BMPs and TGFβs signal
through unique SMAD-mediated transcriptional complexes to regulate ovarian and uterine physiology in mice
and women. Our proposal will take advantage of state-of-the-art CRISPR/Cas9 strategies to manipulate the
mouse genome and DNA-encoded chemical libraries to create novel inhibitors of ACVR2A/2B and BMPR2 and
perform follow-up genetic, proteomic, and biochemical approaches to reach our goals. At the end of 5 years,
we expect to have unlocked key molecular events that are orchestrated by TGFβ family ligands in the female
reproductive tract, thereby accelerating translational research to optimize assisted reproductive procedures for
women and to create the first ACVR2A/2B and BMPR2 specific small molecules to regulate female fertility.

Public health relevance
NARRATIVE Our studies are directly relevant to the missions of the National Institute of Child Health and Human Development and, in particular, research into reproduction, contraception, and population control because transforming growth factor β (TGFβ) superfamily signaling pathways play essential roles in a diversity of developmental and pathophysiological processes including reproductive disorders. Our studies will improve the reproductive health of women, better the quality-of-life of women and their offspring, improve the diagnosis and treatment of reproductive health conditions, including infertility, endometriosis, and preeclampsia, and advance the development of better contraceptive therapies for women. The objectives of this R01 renewal are to mechanistically define the TGFβ family-SMAD-mediated signaling in the ovary, during pregnancy and in maternal diseases and to uncover new drugs for interrogating the functions of BMPs, activins, myostatin, and GDF11 for treatments of clinically important reproductive and non-reproductive diseases.